Immune Exclusion in Cancer Immunotherapy

ABSTRACT
Most patients with solid tumors do not benefit from immune-checkpoint inhibition, emphasizing the need to
improve immunotherapy. We have demonstrated that the T cell-inflamed tumor microenvironment (TME),
characterized by CD8+ T cells and type I/II interferon (IFN) gene expression, is an important cancer
immunotherapy biomarker. Tumor mutational burden may also dictate response with some oncogenic
pathways, such as WNT/β-catenin, known to mediate immune-exclusion and drive the non-T cell-inflamed
TME. Our research group has nominated a core group of molecular targets associated with immune-exclusion
centered at p38 MAPK. p38 is known to regulate macrophages and dendritic cells. However, our data are the
first to describe a tumor cell-intrinsic role for p38 driving the non-T cell-inflamed TME. In this project, we will
investigate tumor cell p38 signaling as a new mechanism of resistance to immunotherapy in carcinogen-
associated head and neck squamous cell carcinoma (HNSCC), lacking infection by human papillomavirus
(HPV). Our research aims are to (1) Establish a causal link between p38, non-T cell-inflamed tumors, and
resistance to ICI in HPV- HNSCC (2) Determine the impact of tumor cell p38 MAPK spatial distribution on T cell
infiltration in HPV− HNSCC (3) Validate and uncover co-activated mechanisms with p38 MAPK in HPV−
HNSCC. We will leverage our lab’s unique role at the center of large-scale, multi-omic approaches as well as
field-leading clinical trial and translational investigation. We will utilize 11 independent cohorts of patients with
HPV- HNSCC. From the public domain, we will include RNAseq and image analysis from three cohorts,
scRNAseq from one cohort, as well as cell line, drug sensitivity and FDA-approved drug databases. These
analyses will be augmented for RNAseq, scRNAseq, and multispectral spatial imaging data from seven other
cohorts organized by our team. These will include immunotherapy naïve patients and patients treated on a
clinical trial we are leading of the p38 inhibitor ARRY-614 + nivolumab. We will utilize a combination of the
computational, machine- and deep-learning analyses plus mechanistic murine experiements in four syngeneic
models as well as in vitro validation studies to pursue our research. Our systemic approach has already
nominated further molecular targets for combination approaches with p38 and immunotherapy. We will validate
these and nominate further molecular targets to enhance cancer immunotherapy.

Public health relevance
NARRATIVE In this project we investigate tumor cell-intrinsic p38 MAPK signaling as a new mechanism of resistance to immune-checkpoint inhibitors. We will address this using large-scale, high-dimensional multi-omics and spatial data as well as biologic correlatives in pre- and on-treatment biopsies from a human clinical trial combining a p38 inhibitor and anti-PD1 immunotherapy in head and neck cancer. We will further utilize a combination of bioinformatics analyses, mechanistic HNSCC syngeneic murine and in vitro experiments to validate our translational observations. Finally, we will identify and validate additional co-activated immune-resistance mechanisms to target in combination with p38 inhibitor and anti-PD1 for future clinical trial evaluation.